LASER MEDIATED GENE TRANSFER IN HIGHER PLANTS

An effective system for introducing exogenous DNA into cells of embryonic calli of Oryza sativa L. cv. Japonica has been established. Plant cells were pretreated in hypertonic buffer to draw some of the water from the cells and were then put into medium of less negative osmotic potential containing exogenous DNA and treated immediately with a laser microbeam (355nm) to puncture holes in the cell wall and membrane. Bright yellow-green fluorescence could be detected inside of cells which had been bathed in a solution containing the fluorescent molecule calcein. B-glucuronidase (GUS) genes were successfully introduced into rice cells as indicated by gene expression both in post-treated cells and in plantlets derived from kanamycin resistant calli that had been treated by this method.